Aim protein-based anti-inflammatory therapeutic for the treatment of IBD

Inflammatory bowel disease (IBD), which is subdivided into ulcerative colitis (UC) and Crohn’s
disease (CD), constitutes a prevalent and growing clinical health problem worldwide. These
diseases are characterized by debilitating symptoms including diarrhea, abdominal pain, and
fatigue, and increased risk of gastrointestinal cancers. In addition, IBD patients have perturbed
intestinal microbiomes, referred to as dysbiosis. The etiology of IBD involves complicated
interactions between immunological genetic variants, environmental factors, and the intestinal
microbiome. Current therapies for IBD include corticosteroids and biologics, which can ameliorate
overproduction of pro-inflammatory cytokines, and other inflammatory mediators, but which do
not treat the microbiome dysbiosis that often triggers or propagates inflammation. In addition, long
term use of corticosteroids and biologics has serious side effects, including osteoporosis, peptic
ulcers, pancreatitis, and impaired wound healing. Therefore, an urgent need exists for more
effective therapies for IBD that treat both inflammation and microbiome dysbiosis. A feature of the
IBD subtype UC is the accumulation of high levels of neutrophils in inflamed colonic tissues and
an excessive neutrophilic response to resident colonic microbes. Our research team at the
University of Oregon, led by the founders of KeyBiome, has identified a novel anti-inflammatory
protein secreted by a zebrafish gut symbiont, Aeromonas, which we named Aeromonas immune
modulator (AimA). We have shown that AimA has potent anti-inflammatory properties, indicated
by a reduction in intestinal neutrophils. Moreover, we have evidence that AimA has microbiome-
modulating activities that include growth inhibition of pro-inflammatory bacterial species.
Therefore, AimA presents an opportunity to develop a therapeutic for IBD, unique in its ability to
both target a primary mediator of inflammation, neutrophils, and facilitate restoration of
microbiome dysbiosis. In this project we will establish proof of concept data for AimA’s therapeutic
efficacy and microbiome-modulating activity in a mouse model of IBD. This will motivate future
development of AimA into a novel human therapeutic to offer patients suffering from IBD a more
effective and safer alternative to current therapies.

Public health relevance
Diseases associated with chronic intestinal inflammation, such as IBD, are a prevalent and growing clinical health problem in the US and across the globe. Current therapies are limited in efficacy and pose serious adverse effects for long-term use. The goal of this project is to develop a novel therapeutic based on a newly discovered bacterial anti-inflammatory protein that will address this dire clinical need.